A Novel Human Virus in Patients with Cryptogenic Liver Disease

Project Summary
A substantial portion of patients with liver disease, ranging from 5% to 30%, have unknown causes beyond
the established etiologies. Unknown etiology is observed across a wide array of clinical phenotypes in liver
disease, such as acute liver failure (ALF), hepatitis, cirrhosis, and liver cancer. These are collectively referred
to as cryptogenic liver disease (CLD). It has long been hypothesized there exist additional human viruses that
cause CLD. In our recent serum virome study, we identified a 387-nt DNA fragment (GenBank MW468091),
named Seq260, from 1 of 9 CLD patients. In a series of experiments of gene-walking, enzymatic digestion,
and rolling circle amplification and analyses, we have demonstrated that Seq260 is a linear single-stranded
DNA. We screened Seq260 in 409 subjects, including healthy blood donors (n=200), hepatitis C virus infection
(n=100), Acute liver failure (ALF) patients with indeterminate etiology (n=50), and liver transplantation (LT)
patients with (n=45) and without known etiology (n=14). Seq260 was detected in 5 CLD patients (1 ALF and
4 LT) and 1 LT patient with nonalcoholic steatohepatitis (NASH)-associated cirrhosis. One patient had Seq260
quantifiable in liver, showing a titer in the liver 7.74 times higher than that in serum (2.4x106 copies/g vs.
3.1x105 copies/mL). Machine learning analysis reached a high score (likelihood) of Seq260 being a eukaryotic
viral sequence. Aggregately, these data lead to our hypothesis that Seq260 represents an unrecognized
human virus with liver tropism. To determine if Seq260 represents a novel hepatitis virus, we bring about a
research plan in the current proposal that consists of three major experiments. First, we will screen Seq260
in CLD patients as well as the controls. We have been granted access to patient specimens from two NIH-
sponsored clinical trials, ALF study group (ALFSG), and the adult-to-adult living donor liver transplantation
cohort study (A2ALL). Unknown etiology accounted for 5.5% and 29.5% respectively in the ALFSG and
A2ALL. Seq260 copy numbers will be quantitated in both serum and liver in Seq260-positive patients with
liver tissue available. Second, we will determine the full genome of the putative virus containing Seq260.
Finally, we will evaluate antibody responses in virus-positive patients and the controls. A peptide-based
serological test will be developed for the putative virus. Peptides will be individually assessed for their
specificity and sensitivity in two virus-positive patients with large volumes of serum available. Selected
peptides will then be combined to ELISA tests for the measurement of antibody (IgG and IgM) responses in
virus-positive and virus-negative patients. Taken together, the proposed study will characterize a novel human
virus and understand its etiological link to liver disease from a clinical aspect. It will expand our knowledge of
the human virome as well as the etiology of liver disease without a known cause.

Public health relevance
Project Narrative In the United States, chronic liver diseases rank 11th and 5th cause for deaths in all ages and in age 44~65- year group, respectively (National Vital Statistics Report 2019), yet up to 30% of patients with chronic liver diseases have no clear etiology. With the identification of a candidate virus in our preliminary studies, the current application aims to characterize this novel human virus and its link with liver disease. The etiological understanding is central to the prevention and management of life-threatening liver diseases.